Management, Dissemination and Training

PROJECT SUMMARY ? MANAGEMENT, DISSEMINATION AND TRAINING The RegulomeDB project is managed by an experienced team of scientist that have been colleagues for over 5 years. We will utilize management practices to promote an efficient team, allowing enhancement and growth of technology and community engagement. We will maintain the highest quality training for out staff to maintain standards for quality and accessibility. We will provide effective tutorials via text or video for use of RegulomeDB.

Public health relevance
RELEVANCE TO PUBLIC HEALTH, PROJECT NARRATIVE The regulation of gene expression controls the determination of cell types, and aberrant gene expression can cause diseases such as cancer. RegulomeDB will enable researchers, clinicians, and sophisticated computer programs to relate DNA variants that lie in previously poorly understood regions of the human genome to possible functions thereby helping us understand the genetic basis of human variation and disease.